Animal Core (Core D)

SUMMARY: ANIMAL CORE (CORE D)
Investigations into brain tumor biology and therapy are best carried out in orthotopic animal models that mimic
the natural milieu of the tumor. The ability to reach meaningful conclusions from these in vivo studies is greatly
enhanced when uniform, readily reproducible animal models are used. The purpose of the Brain SPORE Animal
Core is to provide centralized and specialized animal modeling, thereby achieving uniformity and reproducibility
that enables accurate comparisons between experiments, research groups, and projects in this Brain Cancer
SPORE. To this end, the Core will:
1) Support specialized surgical methods to generate brain tumor models. A key component of many Brain
SPORE studies is the intracranial mouse tumor model. Core D provides surgical expertise in guide screw
placement and intracranial tumor implantation, as well as other specialized surgical techniques.
2) Support all animal strains and tumor cell lines. This includes immunocompromised mice and humanized
mice for human glioma xenografts, immune competent mouse strains for murine xenografts, and
genetically engineered mouse models. In addition to mouse and human glioma cell lines, Core D has over
40 patient derived glioma stem-like cell lines representing all glioma subtypes that are fully characterized
with respect to gene expression, mutation profiles, and in vivo growth characteristics.
3) Support specialized treatment delivery methods. Core D can support complex drug delivery regimens
including intracranial injection, intra-thecal injections, intravenous and intra-arterial injections, and oral
gavage.
4) Support in vivo imaging and sample collection to assess therapeutic efficacy. Core D supports tumor
bioluminescence imaging and MRI and will assist with tissue and blood collection.
The combined expertise of the Animal Core personnel lends itself to productive collaboration with SPORE and
non-SPORE investigators in developing new animal models and unique surgical methods for therapeutic delivery
and data collection. These services are mission critical and one or more of these services are used by all Projects
in this application.

Public health relevance
NARRATIVE: ANIMAL CORE (CORE D) All SPORE Projects and the majority of the projects in the Developmental Research Program and Career Enhancement Program undertake animal experiments to test novel therapeutics. The Brain Cancer SPORE Animal Core provides expert oversight of the design and implementation of all animal experiments. Experienced personnel execute complex surgical procedures and experimental plans, ensuring consistency between experiments and investigators.